Patterned Electrical Stimulation of the Retina for High-Resolution Prostheses

Project Summary/Abstract The long-term objectives of my research are to understand the visual signaling function of the retina and to exploit this knowledge for the treatment of blindness. The major goal of the proposed work is to develop techniques for precise, patterned multi-electrode stimulation of the retina, with the purpose of advancing the development of high-resolution retinal prosthetic devices to replace the function of retinas damaged by degeneration. The specific aims involve (1) evoking electrical activity in the major high-resolution ganglion cell types of the primate retina, as well as several ganglion cell types in the degenerating rat retina, (2) selectively stimulating individual cells to achieve the elementary spatial and temporal resolution of normal visual signals transmitted to the brain while avoiding stimulation of axons, over a range of retinal eccentricities, and (3) evoking spatial and spatiotemporal patterns of activity in populations of ganglion cells that can mimic the complex visual signals normally transmitted to the brain. We will apply our unique technology to simultaneously and independently stimulate and record from many ganglion cells in vitro, using an array of electrodes comparable to but much smaller and denser than those used in current retinal prosthetics. We will exploit this technology to develop new methods for focal and patterned stimulation to mimic visual signals, including development of novel technologies to target the central retina. We will also leverage our experience with the primate retina and the P23H mutant rat model of retinal degeneration to maximize the relevance of the findings for treating blindness. Our vision is that the work will aid the design of the next generation of retinal prosthetic devices to support advanced visual functions such as object recognition and motion sensing in human patients.

Public health relevance
Project Narrative The goal of the proposed work is to advance the development of high-resolution retinal prosthetic devices to treat blindness, using electrophysiological recording and stimulation of the primate and degenerating retina in vitro. Our approach leverages a specialized multi-electrode recording and stimulation technology designed to resemble future prosthetic devices, with an emphasis on emulating naturalistic visual signals and interfacing with the parallel pathways for high-resolution vision in primates. This unique approach will further the design of the next generation of retinal prostheses -- devices that can support advanced visual functions such as object recognition and motion sensing in human patients. __SpecificAimsTextDelimiter__ Specific Aims The purpose of epiretinal prostheses is to restore visual function by evoking electrical activity in retinal ganglion cells (RGCs) that conveys useful visual information to the brain. Prototype devices elicit coarse phosphenes in blind patients using large, widely spaced electrodes that stimulate many RGCs indiscriminately. To mediate advanced visual function, future devices must evoke high-resolution spatiotemporal patterns of electrical activity in RGCs of different types, which project to distinct targets in the brain, and must do so in degenerated retinas. Little is known about whether and how this can be achieved. Our goal is to build the foundation for advanced retinal prosthetic devices, by developing strategies for focal, spatiotemporally patterned electrical stimulation of multiple RGC types in normal and degenerating retina [at a range of retinal eccentricities]. We will exploit our unique high-resolution, multi-electrode stimulation and recording approach: Aim 1. Electrical stimulation of distinct RGC types in primate and degenerating rat retina We have shown that mammalian RGCs can be directly electrically activated with short latency and high temporal precision, using small electrodes and low current levels. However, it is unknown how the multiple distinct RGC types in the primate retina, which transmit different visual information to distinct targets in the brain, differ in their responses to electrical stimulation. Furthermore, retinal degeneration could differentially affect responses in different RGC types, selectively disrupting some of the parallel pathways for vision. We will characterize responses to electrical stimulation in the high-resolution RGC types of macaque monkeys, as well as several RGC types in transgenic P23H rats undergoing retinal degeneration: 1A. What are the thresholds and timing of responses to electrical stimulation in the numerically dominant RGC types in primate retina (ON and OFF midget, ON and OFF parasol, small bistratified)? 1B. How does electrical activation of distinct RGC types change during retinal degeneration in P23H rats? Aim 2. Selective stimulation of individual RGCs and avoidance of axons The spatial resolution of vision is set by the lattice-like organization of the receptive fields of each distinct RGC type. To approach this resolution with a prosthesis, we must be able to selectively activate an individual RGC while not activating other nearby RGCs of the same or different types. [This is of particular importance in the central retina, where RGC density is likely to exceed electrode density]. We have shown that in some cases, selective activation can be accomplished with a single electrode, but in others unwanted activity is evoked in nearby RGCs and axons. A possible solution is to inject current through multiple electrodes simultaneously, in a spatial arrangement that targets one cell. [We will test this approach over a range of retinal eccentricities]: 2A. Under what conditions can a midget, parasol or small bistratified cell be selectively activated with a single electrode, without activating other RGCs or passing axons? 2B. Can the responses to stimulation with multiple electrodes be predicted quantitatively, using data gathered with individual and pairs of electrodes and a quasi-linear model? 2C. What spatial patterns of stimulation can activate a single RGC while minimizing activation of other RGCs? 2D. Can activation of passing axons be avoided using axial or transverse stimulation with electrode pairs? 2E. How does selective activation vary with retinal eccentricity and electrode density and geometry? Aim 3. Evoking spatiotemporal patterns of activity in RGC populations Effective transmission of visual information to the brain requires activation of many RGCs in spatiotemporal patterns that resemble natural visual signals. However, it is unclear how electrical stimuli designed to activate single cells will interact when superimposed to evoke activity in multiple cells. Specifically, the electric field may be disrupted by interactions between electrodes, and RGC activity may be disrupted by subthreshold stimulation from preceding stimuli. By simultaneously recording and stimulating complete local populations of RGCs, we will develop strategies to mimic the spatiotemporal patterns of activity that occur in normal vision: 3A. Can a desired spatial pattern of activity in a complete mosaic of RGCs be reproduced by stimulating cells with optimized spatial patterns chosen according to the quasi-linear model (Aim 2B)? 3B. Can a desired spatiotemporal sequence of activity in a complete mosaic of RGCs be evoked by stimulating cells with the delayed superposition of selective stimulation patterns optimized for each cell? 3C. Can electrical stimulation precisely mimic behaviorally relevant visual signals, such as population responses to a flash or a moving bar?